Discipline C: Radiochemistry, Admin Core

Project Summary/Abstract ? Admin The designated laboratory director will be responsible for the overall administration, management and coordination of the project. He will be supported in his efforts by the designated quality assurance/quality control manager. Both of them will interact with the laboratory staff (Graduate Research Assistants) and provide them with the necessary training required to successfully compete the proposed work. In addition, this project will utilize accounting and purchasing resources provided by the Department of Environmental & Radiological Health Sciences in the College of Veterinary Medicine and Biosciences at Colorado State University.